Increasing the Feasibility, Impact, and Equity of the Medicare Annual Wellness Visit (AWV)

Project Summary
Older adults vastly underutilize evidence-based preventive health services that are proven to reduce serious
illness, morbidity and mortality. In fact, fewer than half of adults aged 65 and older are up-to-date on evidence-
based cancer screenings and vaccinations recommended by expert committees (e.g., the USPSTF and
CDC/ACIP). Those at greatest risk for receiving poor preventive care include racial and ethnic minority groups
and persons of low socioeconomic status. Yet interventions to remedy this underutilization in older adults have
mostly targeted individual preventive health services, rather than the totality of services needed by patients.
The 2011 Medicare establishment of the Annual Wellness Visit (AWV) is a great and underused opportunity to
respond to the National Cancer Institute's calls for multilevel interventions that address both the supply and
demand for vastly underutilized preventive health services. This free-to-the-patient AWV visit gives providers
dedicated time to focus on preventive health services.
We developed a multilevel intervention to increase AWV use that successfully increased AWV utilization in 3
small (2-5 provider) pilot practices. The intervention addresses the complexities of increasing AWVs at patient
(demand for services), provider (supply of services), and practice levels. It combines electronic health record
(EHR)-generated information and tools with practice redesign tools and approaches to inform providers and
patients about the preventive health services needed by individual patients. This proposal's goal is to conduct
a pragmatic trial to evaluate the effect of the intervention on increasing AWV and preventive health services
utilization. We will implement the intervention in geographically and racially/ethnically diverse community-
based practices, Federally Qualified Health Centers, and academic health system practices. Practices include
small to mid-size primary care practices (including solo practices), which typically are under-represented in
research. Specific aims of this study are to: 1) Evaluate the effect of the intervention on use of a) AWVs and b)
USPSTF and CDC/ACIP-recommended preventive services in 3 different types of practice settings; 2)
Evaluate the effect of the intervention on reducing racial/ethnic disparities in AWV utilization; and 3) Evaluate
factors affecting implementation and sustainability of the intervention tools and approaches, implementation
strategies, and intervention effect in diverse patient settings. Implemented via video conferencing and remote
deployment of EHR tools, this low-cost intervention could easily be disseminated to small and solo practices
across the country. The anticipated increase in patient use of preventive health services will improve
population health and lower mortality, particularly in at-risk racial/ethnic minority patients.

Public health relevance
Relevance to Public Health Evidence-based preventive health services are vastly underutilized by older Americans. This proposal’s promising multilevel intervention will stimulate greater use of the Medicare Annual Wellness Visit, an established but underused mechanism that gives providers dedicated time to focus on preventive health services. The anticipated increase in preventive health services stemming from greater Annual Wellness Visit use will improve population health and lower mortality, particularly in at-risk racial/ethnic minority patients.